NOVEL MODULATORS OF ALCOHOL INDUCED METABOLIC AND LIVER INJURY

DESCRIPTION (provided by applicant): Rationale: Chronic ethanol-induced down regulations of silence regulator gene 1 (SIRT1) and peroxisome proliferator receptor coactivator 1 alpha (PGC1alpha) and up-regulation of PGC12 affect hepatic lipid oxidation and lipogenesis leading to fatty liver and consequent injury. We show that dietary low omega3-fatty acids (omega3FA), but not high omega3FA, significantly decreased serum and liver lipids, while Soy Proteins (SP) had similar lipid lowering effects. Therefore, it is clinically relevant to prove that these two novel modulators attenuate alcohol-induced fatty liver and injury potentially by regulating these opposing PGC11 and PGC12 signaling pathway genes. Preliminary Studies: Our rationales are based on our publication records (12 Publications, 1 Review article, 1 book &21 Abstracts in the past 5 years), and on strong preliminary data that are summarized below: Low omega3FA &SP opposed the actions of chronic alcohol by (a) Reducing serum lipids with concomitant decreased fatty liver;(b) Attenuating the up-regulation of hepatic mRNAs of PGC1beta, SREBP1c and their target lipogenic pathway genes;(c) Preventing the down-regulation of hepatic mRNAs of SIRT1 and PGC1alpha and their target fatty acid oxidation pathway genes;(d) Preventing the hepatic increase in acetyl-PGC1alpha, its inactive form;(e) Restoring impaired hepatic fatty acid oxidation and gluconeogenesis;And (f) Restoring the hepatic level of PO4AMPK that was decreased by chronic alcohol treatment. (g) By Western blots, we demonstrated concomitant changes in levels of mRNAs of PGC1alpha and PGC1beta signaling pathway genes and the corresponding enzyme proteins caused by chronic alcohol. (h) That PGC1alpha plays a critical role in alcohol- induced fatty liver was demonstrated by dramatic increase in hepatic lipid score in PGC1alpha-KO mice. (i) PGC1beta seems to play a secondary role because PGC1beta-KO mice still developed alcoholic fatty liver albeit less pronounced than in PGC1alpha-KO mice, presumably because of ethanol-mediated strong inhibition of PGC1alpha. Specific aims: Based on these rationales and preliminary findings we will address the following specific aims: Specific Aim 1. Effects of omega3FA and SP on Chronic Ethanol-induced Increases in Plasma and Hepatic Lipids and Lipoproteins, AST, ALT and Their Correlation with Liver Histopathology. Specific Aim 2. Mechanisms of Actions of omega3FA and SP on Ethanol-induced Up-regulation of Hepatic Lipid Anabolic Transcriptional Coactivators, Lipogenic Genes and de novo Lipid Synthetic Rates. Specific Aim 3. Mechanisms of Actions of omega3FA &SP on Ethanol-induced Down-regulation of Hepatic Lipid Catabolic Transcriptional Coactivators, Lipid Oxidizing Genes &Fatty Acid Oxidation Rates. Methods of Approach: PI and his team will accomplish these specific aims by using rodents as experimental models with their expertise in molecular biology, immuno- and histo-chemistry and biochemical approaches. PI will also use PGC1alpha-KO and PGC1beta-KOs mouse models to conclusively prove their specificities in the actions of ethanol, Low 3FA &SP via these signaling pathways in causing/preventing alcoholic fatty liver and injury.

Public health relevance
Alcohol-induced down regulations of SIRT1 and PGC11 and up-regulation of PGC12 essentially affect key components of liver physiology leading to Hepatosteatosis. Since low ω3-fatty acids (ω3FA) and Soy Protein (SP) are potential modulators of PGC11 via SIRT1 and PGC12, PI proposes that it is therapeutically pertinent to test whether alcoholic Hepatosteatosis can be attenuated by low ω3FA and SP and to elucidate their mechanism/s of action.